Neural Markers of Developmental Delays in Premature and Full Term Infants

Project Summary/Abstract
Premature infants are vulnerable to long-term social, cognitive, and behavioral difficulties. However, not all
premature infants go on to have developmental delays. Moderate to late preterm infants (born after 32 weeks)
represent a missed clinical population as they do not automatically qualify for federally provided health
screening and intervention programs. Therefore, the investigation into the neural mechanisms underlying
heterogeneities in behavioral development is a promising approach to improve our ability to identify infants in
need of additional services and inform treatment responses. This is also an important public health mission
and a NICHD funding priority. The proposed K99 study will chart brain development using
electroencephalography (EEG) during well-baby visits (4, 9, and 12 months) at a primary care clinic and a
follow-up lab visit (24 months). Participants (N = 720 target recruitment) will be drawn from an ongoing R01 (PI
Nelson: 5R01NS120986) study that examines if EEG is feasible in the context of a primary care facility and
aids in the early identification of children who go on to receive an autism diagnosis. To this end, I will assess
the longitudinal trajectories of brain development in preterm and full term infants across the first two years of
life (aim 1). Next, I will determine the link between brain development and development delays (aim 2). Finally,
in the R00 phase, I will recruit and longitudinally follow a new sample of preterm (1 month chronological, 1
month corrected, 4 months chronological, and 4 months corrected) and full term infants (1 month chronological
and 4 months chronological). Using a multimethod neuroimaging approach (simultaneous functional Near-
Infrared Spectroscopy and EEG) I will explore when disruptions in cerebral blood flow responses and brain
activity first emerge and their associations with developmental delay. Overall, understanding
neurodevelopmental processes before and when delays first emerge provides a tractable approach to
improving psychological outcomes and well-being across the lifespan. The training and experience gained
during the award period will support my transition to becoming an independent investigator and will contribute
to my long-term research goals of investigating infant brain mechanisms underlying heterogeneities in social
and cognitive development.

Public health relevance
Project Narrative Infants born prematurely represent a vulnerable population that has an elevated likelihood of developing social and cognitive impairments. The present study aims to use non-invasive infant neuroimaging methods to identify the neural mechanisms underlying social and cognitive difficulties in both preterm and full term infants. Through charting brain and behavioral development longitudinally we hope to inform early identification and intervention strategies.